Post-transcriptional regulation of stem and progenitor cell function

ABSTRACT
The genome is transmitted from one generation to the next by two highly specialized cell types, sperm and
egg. In the adult testis, spermatogonial stem cells continuously produce progenitors that rapidly expand their
population (transit-amplify) before undergoing terminal differentiation into sperm. Across tissues, cell state
transitions from stem cell to progenitor to differentiated cell require regulated gene expression programs. Post-
transcriptional mechanisms that regulate RNA, from splicing through translation, play a major role in shaping
these gene expression programs. My research program seeks to define how post-transcriptional regulation
shapes gene expression programs to support the function of spermatogonial stem and progenitor cells, using
mouse as our model. We leverage single cell methods as well as approaches unique to spermatogenesis to
provide enhanced stage-specific insights into progenitor function. We will focus on two Areas:
Area 1: During spermatogenesis, retinoic acid (RA) signaling induces early progenitors to form committed
progenitors via canonical regulation of transcription and noncanonical regulation of translation. We have
demonstrated that RNA-binding protein and translational regulator DAZL supports the formation of committed
progenitors, but whether DAZL’s activity affects RA-induced molecular changes remains unclear. Here, we will
test the hypothesis that DAZL enhances RA-mediated changes in transcription and translation to induce
formation of committed progenitors.
Area 2: Committed spermatogonial progenitors enter terminal differentiation when they initiate meiosis in
response to RA signaling. RA activates gene expression of Stra8 and Meiosin, which encode a heterodimeric
transcription factor that drives the initiation of meiosis. We recently discovered that the RA-dependent
upregulation of Meiosin gene expression requires the RNA-binding complex MEIOC-YTHDC2-RBM46, which
mediates mRNA degradation of transcriptional repressors of Meiosin. Based on these data, we proposed the
conceptually novel model that committed progenitors must acquire the molecular competence to initiate
meiosis in response to RA. Furthermore, this competence is regulated by MEIOC-YTHDC2-RBM46
destabilizing mRNA. Here, we propose to expand on this model. We will define the mechanism by which
MEIOC-YTHDC2-RBM46-bound mRNAs are degraded, identify MEIOC’s molecular function within the
complex, and determine whether genetic ablation of transcriptional repressors targeted by MEIOC-YTHDC2-
RBM46 is sufficient to rescue the competence of Meioc knockout committed progenitors.
Our proposed research directions will define how post-transcriptional regulation interacts with
transcriptional networks to support spermatogonial stem and progenitor cell function, with implications for
human reproductive health. More broadly, our studies will inform how post-transcriptional mechanisms may be
implemented in other contexts of normal cellular differentiation and co-opted in cancer.

Public health relevance
PROJECT NARRATIVE During the adult lifespan, spermatogonial stem cells continuously enter the differentiation process of spermatogenesis to produce sperm. This differentiation requires regulated gene expression programs, which are in part shaped by the post-transcriptional control of RNA. The goal of this proposal is to study post- transcriptional mechanisms that regulate the differentiation of spermatogonial stem cells, and discoveries made from this work will provide insights that are broadly relevant to human fertility, testicular cancer, as well as stem cell function in tissues across the body.